Development of Sialic Acid-GFP Sensors, a Cancer Associated Sugar, For Tumorigenic Mechanistic Elucidation and Glycan Therapeutic Development

Title: Development of Sialic Acid-GFP Sensors, a Cancer Associated Sugar, For Tumorigenic
Mechanistic Elucidation and Glycan Therapeutic Development
Project Summary: Cancers utilize the sugar Sialic Acid (Sia) to engage in immune evasion,
multidrug resist, and alter pro-inflammatory pathways, all resulting in survival. Three non-
canonical forms of Sia exist that are found on cancer’s cell surface: acetylated-Sia (Neu5,9OAc),
5-N-glycolylneuraminic acid (Neu5Gc), and deacetylated neuraminic acid (Neu5Ac). These forms
of Sia contribute to increased metastasis and immune evasion. Our lab was the first to identify
that lung and colon cancers overexpress deacetylated-Sias inhibiting NK mediated cytotoxicity
yet the relevant amount of deacetylated-Sias needed to propagate the mechanism of action
remains unknown. Despite the evidence concerning the importance of glycan modification, further
mechanistic elucidation that underpins each process (immune evasion, multidrug resistance, and
metastasis) are incomplete due to the lack of methods to detect and quantify each Sia form thus
a critical need for the development of sensors that will target each form Sia exists. Our long-term
goal is to develop a toolkit of sialic acid targeting sensors that will allow for facile quantification of
each cancer associated form of Sia in which to use to elucidate tumorigenic mechanistic
thresholds. Our overall objective is to optimize sialic acid-GFP sensors to target acetylated and
deacetylated sialic acids on the surface of colon cancer cells. Our central hypothesis is that Sia
targeting sensors can be constructed utilizing Sia binding proteins. The formation of this
hypothesis is based on our previous work in which we developed sensors for unconjugated
ubiquitin using IsoT and the ubiquitin-associated domain. The rationale (and positive impact) that
underlies the proposal is that the development of sensors to quantify the cancer related forms of
Sia will provide mechanistic elucidation and lead to the robust development of glycan targeted
therapies to mitigate cancer’s ability to survive. Performing the following specific aims will test the
central hypothesis and accomplish the overall objective: develop sensors of sialic acid and its
variants via SiaP, NanS, and SubAB, which bind to Neu5Ac, Neu5,9OAc, and Neu5Gc,
respectively (Aim 1). We will then quantify binding and detection of Neu5Gc, Neu5,9OAc and
Neu5Gc-GFP sensors on the surface of colon cancer cells via our optimized and published sialic
acid cell surface binding assay with CRISPR-Cas 9 cancer cell lines in which the presence of
Neu5Gc, Neu5Ac, and Neu5,9Ac has been previously confirmed and characterized (Aim 2). The
binding of each sensor sensors will be measured via flow cytometric analysis.

Public health relevance
Project Narrative The collaborative project is relevant to public health because a toolkit of sialic acid (Sia) targeting sensors will enable quantification of each cancer-associated form of Sia, improving our understanding of mechanisms behind cancer's ability to evade the immune system, resist multiple drugs, and spread more easily. By developing these strategies, there is the potential to counter cancer's ability to survive and create effective glycan-targeted therapies. As such, the collaborative research aligns with the goal of NIH to reduce illness and disability.